Determining mechanisms of PRC2-mediated disease using Drosophila

PROJECT ABSTRACT/SUMMARY
Normal development requires tightly controlled gene expression to precisely regulate tissue patterning and
failure to properly control the expression profiles can lead to disease. Post-translational modifications to the
histone proteins, which package the DNA genome, can regulate expression of the underlying genes by making
DNA more or less available to transcriptional machinery. Polycomb repressive complex 2 (PRC2), a highly
conserved histone methyltransferase, maintains gene repression during development by facilitating chromatin
compaction. PRC2 catalyzes the methylation of lysine 27 on histone H3 (H3K27me3) and loss of this epigenetic
mark is associated with a number of developmental diseases. Diffuse intrinsic pontine glioma (DIPG), a deadly
pediatric brain cancer, is caused by a lysine-to-methionine mutation on histone H3 (H3 K27M) that inhibits PRC2,
resulting in a near-total loss of H3K27me3. Similarly, inhibition of PRC2 by the aberrant expression of EZHIP
results in another pediatric glioma, posterior fossa ependymoma type A (PFA). By contrast, loss-of-function
mutations in two core PRC2 subunits result in Weaver syndrome, a congenital disorder marked by somatic
overgrowth and cognitive delays, but not cancer. The disparate clinical phenotypes caused by these disease
alleles may be the result of different modes of PRC2 inhibition and the tissue-specific developmental context in
which they are expressed. This proposal seeks to leverage a combination of genetic and genomic approaches
to define the importance of distinct modes of PRC2 inhibition and developmental context to clinical phenotypes.
Because PRC2 is highly conserved across species, Drosophila melanogaster will be used to test the relative
contributions of each of these features to disease using an array of experimental approaches. The effects of
disease alleles on tissue patterning, PRC2 function, and gene regulation will be assessed in a dynamic,
developmental context. Genes that modulate the effects of disease alleles, including potential therapeutic
targets, will be systematically tested. These approaches bridge the expertise of the Harrison lab (gene
expression and development) and the Lewis lab (chromatin regulation and cancer) to address fundamental
mechanistic questions about these disease alleles. The abundant resources at the University of Wisconsin
School of Medicine and Public Health and the UW Carbone Cancer Center provide an ideal location to carry out
the proposed work. Together this work will define mechanistic differences between PRC2-disease alleles and
will reveal underlying differences that may lead to their distinct, devastating clinical phenotypes. Completion of
this research will ensure development of experimental, mentorship, clinical, and communication skills that will
enable successful transition to a career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Tissue-specific patterns of gene expression affect the oncogenic potential of proteins that regulate the epigenetic state, necessitating studies within the context of development. To determine the mechanistic contributions of developmental context to disease phenotype, we will leverage the powerful set of tools available in Drosophila melanogaster to establish disease models of oncoproteins that inhibit PRC2. This will enable us to identify modifiers of the disease phenotype, which may hold promise as targets for novel therapeutic strategies.